Oral Health and Dental Care Utilization Among Formerly Incarcerated Older Adults in the United States

ABSTRACT. Oral health is a vital component of overall health, especially in older adulthood. Nonetheless, as
individuals age into older adulthood, they experience more significant oral health problems and challenges with
utilizing dental care. However, there is limited research about how earlier life characteristics, especially
stressful experiences, influence older adults' oral health and dental care. A widespread stressful life event in
the United States with potentially harmful implications for oral health is incarceration. The United States
currently has the highest incarceration rate in the world and has experienced a nearly 300% increase in the
incarceration rate of older adults over the past three decades, leaving millions of older adults either currently or
formerly incarcerated. Prior research among adolescents and young adults finds incarceration is a risk factor
for worse oral health and not utilizing dental care services. However, no previous research has assessed the
impact of earlier life incarceration on oral health and dental care among older adults over 50. The proposed
study breaks new ground by providing the first comprehensive investigation of the influence of incarceration on
the oral health and dental care of older adults in the United States. To study this topic, we will leverage
longitudinal data from the Health and Retirement Study (n = 14,293)—the only nationally representative
dataset of individuals over 50 in the U.S. with measures of oral health, dental care utilization, and incarceration
history. This study has three aims. Aim 1 will examine the association between incarceration history and
incarceration duration, with edentulism and dental care utilization, focusing on variations by race and ethnicity,
socioeconomic status, and overall health. Aim 2 identifies socioeconomic factors and health behaviors that
mediate the relationship between the history of incarceration and edentulism and dental care utilization. Aim 3
uses the longitudinal nature of the Health and Retirement Study from 2014 to 2022 to assess how
incarceration history corresponds to trajectories of edentulism and dental care utilization over time. The
conclusions of this research can provide an evidence base necessary to understand oral health inequities
among formerly incarcerated older adults and spur interventions to connect formerly incarcerated older adults
to dental care systems to improve oral health and overall health.

Public health relevance
Public Health Relevance Statement. Approximately 1-in-15 community-dwelling adults over 50 years old are formerly incarcerated, and incarceration history places this population at increased risk for chronic and geriatric disease. We will leverage data from the Health and Retirement Study to conduct the first comprehensive study of the impact of incarceration on oral health and dental care among older adults.